Potentiate Cav3.3 To Treat Cognitive Deficits Associated with Impaired Sleep Spindle

Project Summary/Abstract
Sleep spindle is a hallmark brain oscillation occurring in NREM (non-rapid eye movement) sleep that reflect
intrinsic thalamocortical offline processing. Spindles are waxing and waning bursts of 12-15 Hz oscillations
that originate in Thalamic Reticular Nucleus (TRN) when its neurons undergo bursting firing, and TRN-
Thalamic Relay network oscillates at spindle frequency through the reciprocal connection. Sleep spindles are
markedly reduced in schizophrenia patients as well as in Alzheimer patients, two very different CNS disorders
yet both demonstrated significant altered sleep spindle properties associated with cognitive impairment. We
hypothesize that hypofunctional TRN may underlie the risk/symptoms of these two devasting illnesses.
CACNA1I is encode the α1 functional core of the CaV3.3 voltage-ˇgated calcium channels, and its expression
is enriched in TRN. We have discovered two novel chemical scaffolds that potentiate CaV3.3 function, and this
proposal aims to deliver in vivo ready Cav3.3 positive modulators. This multidisciplinary effort is expected to
yield a panel of incisive pharmacological reagents to enhance CaV3.3 function in the brain and nominate
candidates for preclinical development for treating cognitive impairments in schizophrenia patients.

Public health relevance
Project Narrative Sleep spindles are brain oscillations during NREM (non-rapid eye movement) sleep that are generated in the thalamus and can be measured by encephalogram (EEG). Sleep spindles properties correlate with cognitive performance, and are impaired in severe psychiatric disorders including schizophrenia. This proposal delivers a novel set of potent and highly selective potentiators of a calcium channel to restore the deficits in sleep spindles and associated cognitive function seen in severe psychiatric and neurological disorders.